Mechanisms of atherosclerotic cardiovascular complications in COVID19

PROJECT SUMMARY
The coronavirus disease 2019 (COVID-19) pandemic, caused by severe acute respiratory syndrome coronavirus
2 (SARS-CoV-2), remains a global health concern and despite the fast-track development of vaccines and the
imminent prospective of new antiviral drugs, is expected to become endemic. COVID-19 is associated with
atherosclerotic cardiovascular (CV) complications like acute coronary syndrome (ACS), Myocardial Infarction
(MI) and stroke, a risk that remains high for up to one year following recovery, but the underlying mechanisms
are poorly understood. In preliminary work using atherosclerotic tissue from COVID-19 patients at autopsy and
subjects who recovered from COVID-19, along with an ex-vivo SARS-CoV-2 model of human vascular explants,
we identified SARS-CoV-2 viral material in human plaques that persists in plaques of patients who recovered
from COVID-19. Single cell RNA sequencing (scRNAseq) of human atherosclerotic plaques identified high levels
of neuropilin-1 (NRP1), a receptor for SARS-CoV-2 entry, in plaque macrophages and foam cells. NRP-1
blockade abrogated the accumulation of viral material in SARS-CoV-2 treated human plaques. These data
suggest that SARS-COV-2 or its viral components can accumulate in human plaques, where they exacerbate
inflammation and disease progression by engaging NRP-1. Using the Syrian Golden hamster model, that
faithfully mimics human SARS-CoV2 infection, we found that viral replication in the heart, lungs and olfactory
bulb of infected hamsters did not correlate with expression levels of Ace2, supporting a role for alternative
mechanisms of viral entry such as NRP-1. Moreover, this model revealed acute and sustained tissue-specific
inflammatory responses (i.e. Nfkb1, Il6, Il1b) in several tissues due to the persistence in the circulation of
noninfectious viral RNA debris (vRNA) for up to several weeks following viral clearance. Based on these exciting
preliminary data, we propose two independent aims to study how SARS-CoV-2 aggravates plaque inflammation
and atherosclerosis and to determine the molecular basis for the increased risk of acute and long-term CV events
in COVID-19 patients. In Aim 1 we will identify the role of NRP-1 in SARS-CoV-2-induced atherosclerotic plaque
inflammation and atherosclerosis progression. Aim 2 will identify the contribution of SARS-CoV-2 vRNA debris
to inflammation and atherosclerosis. We will also determine the effect of persistent vRNA on inflammation and
atherogenesis following viral clearance and recovery from COVID-19. These studies will address important gaps
in knowledge on the effect of SARS-CoV-2 infection on plaque inflammation and atherosclerosis, and will tackle
the molecular basis for the increased CV in patients with COVID-19. We foresee that this information will help
guide the future design of precise therapies to prevent CV outcomes in patients with COVID-19.

Public health relevance
PROJECT NARRATIVE These studies are relevant to public health for two reasons. First, they will identify the effect of SARS-CoV-2 infection on plaque inflammation and atherosclerosis progression and determine whether these effects are mediated by a new SARS-CoV-2 entry factor. Secondly, they will determine how noninfectious viral debris contribute to plaque inflammation and aggravated atherosclerosis and whether their persistence constitutes the molecular basis for the increased risk of long term CV events.